KIDNEY CONTROL OF ERYTHROPOIETIN PRODUCTION

The primary objective of the current proposal continues to be to determine the mechanism by which hypoxia stimulates kidney production of erythropoietin and the possible involvement of prostaglandins, the beta-adrenergic nervous system and cyclic nucleotides in this process. We postulate that prostaglandins/prostacyclin released during hypoxia trigger adenylate cyclase in a renal cell to increase cyclic AMP levels which initiate a cascade of events leading to the production of erythropoietin. The work which will be undertaken during the next year will be: 1) to determine the role that adenylate cyclase activation by prostaglandin E2 and prostacyclin may play in kidney production erythropoietin as a possible mechanism by which hypoxia triggers kidney production of erythropoietin; 2) assess the role of hypoxemia on calcium entry into renal cells to activate phospholipase initiating the prostaglandins cascade leading to erythropoietin production; 3) to study the effects of several prostaglandins E and prostacyclin analogues in the mechanisms of erythropoietin induced erythroid progenitor cell (FU-E and BFU-E) activation; 4) to study further the involvement of prostaglandins and prostacyclins in beta-2 adrenergic activation of kidney production of erythropoietin; 5) characterize the PGE2 and beta-2 adrenergic-adenylate cyclase coupling in the induction of erythroleukemia cells (mouse spleen Friend virus) and bone marrow cells from patients with myeloproliferative disorders; and 6) attempt to trigger erythropoietin production in isolated kidney glomeruli in tissue culture with hypoxia, steroids, prostaglandins and beta-2 agonist drug.